Determining the mechanisms that cause persistent MRSA bloodstream infection by tracking in-host evolution

Project Summary/Abstract
Bloodstream infection (BSI) due to methicillin-resistant Staphylococcus aureus (MRSA) carries ~20%
mortality [1, 2]. MSRA displays tolerance to antibiotic killing [11], has a propensity to cause persistent BSI (pBSI)
[3], and the duration of pBSI predicts mortality [2, 12-14]. MRSA rarely acquires frank antibiotic resistance during
pBSI [3], highlighting tolerance as an important cause of poor patient outcomes. Antibiotic tolerance is a complex
trait, which is distinct from resistance, and there are significant barriers to its study in vivo that have hampered
progress on understanding the most important mechanisms in clinical settings. In this proposal, we advance an
innovative genetic screening approach to overcome these barriers. Episodes of MRSA-pBSI that occur in
different patients can be viewed as biological replicates of a naturally occurring experiment in microbial evolution.
As bacterial population sizes collapse due to selection from antibiotic and immune pressure, tolerant mutants
will become enriched. Mutations that arise independently in the same genetic loci at a rate that exceed chance
alone, are biologically meaningful. In preliminary studies, using this “genotype-first” approach, we found evidence
for in-host evolution of two genetic pathways strongly linked to antibiotic tolerance. Our central hypothesis is that
mutants that arise during the treatment of MRSA-pBSI contain genetic adaptations for antibiotic and immune
tolerance. We propose to identify and characterize these pathways through the following specific aims:
Aim 1. Determine which genes evolving during MRSA-pBSI are associated with antibiotic tolerance and
energy imbalance. Tolerance mechanisms often involve perturbations in metabolism, causing a ‘low energy’
state that leads to slow turnover of antibiotic targets [4, 5]. Such perturbations could arise through a variety of
redundant pathways that converge on energy dysregulation. Alternatively, in vivo conditions may stress specific
nodes in the cell’s metabolic networks and some pathways may dominate the antibiotic tolerance landscape. We
will utilize our genetic screening approach to identify antibiotic tolerant mutants and determine which genes
evolving during MRSA-pBSI are associated with antibiotic tolerance and energy imbalance.
Aim 2. Determine if TCA cycle defects evolve during MRSA-pBSI due to a host-pathogen-drug
interaction. Antibiotic tolerance can be induced by harsh environments and a leading model is that host immune
pressure in the form of phagocyte-derived reactive oxygen species induces S. aureus into a drug-tolerant state
by reducing flux through the tricarboxylic acid (TCA) cycle [6]. In our preliminary data, we identified TCA cycle
mutants that evolved during MRSA-pBSI. If these mutants evolved by outcompeting wild-type MRSA in
phagosomes, they will display a fitness advantage in this setting. We will utilize these mutants to test this model
directly, by performing experiments where we infect phagocytes and measure survival and drug tolerance.
This study is important for understanding the fundamental biology of persistent MRSA infection and the
mechanisms underlying antibiotic tolerance in vivo. This information will inform the design of novel therapies.

Public health relevance
Project Narrative Methicillin-resistant Staphylococcus aureus (MRSA) bloodstream infection is associated with high mortality despite antibiotic drug therapy. The mechanisms underlying this drug-tolerant state are poorly defined in clinical settings. This proposal uses an innovative genetic screening method to elucidate these mechanisms in vivo and will provide critical information for identifying novel approaches to therapy.